An Ultrasensitive Flow Cytometry System for Multiparametric Analysis of Therapeutic Anti-Aging Extracellular Vesicles

PROJECT SUMMARY
Extracellular vesicles (EVs) are small, lipid bound vesicles that are secreted by cells. Originally thought to serve
little purpose, EVs have been gaining significant interest due to their promise as therapeutics for a wide range
of indications including skin repair in wound healing and photoaging, and central nervous system (CNS) repair,
including the treatment of neurogenerative diseases such as Alzheimer’s and Parkinson’s diseases. As EVs are
found in a variety of physiological fluids including blood, urine, ascites and cerebral-spinal fluid, they also show
great promise as minimally invasive disease biomarkers. However, due to their very small size, many ranging
from 1 μm down to as small as 30 nm, they are exceedingly difficult to study.
Characterization of EVs is critical to understanding function. This characterization includes not only EV size, but
also the complement of molecular cargo that they carry. While some techniques such as nanoparticle tracking
analysis (NTA) can accurately size particles, they have severe limitations in analyzing their molecular content.
Other methods can determine molecular contents, but typically only as a bulk molecular analysis, preventing the
cross-correlation of the expression of multiple markers in individual EV particles. Most of the current analysis
methods are low throughput, laborious, and/or require significant technical expertise. However, one technique—
nanoparticle flow cytometry (NP-FC)—has the capability to provide researchers with simultaneous
investigation of size and multiparameter analysis of molecular cargo on a particle-by-particle basis.
While most off the shelf flow cytometers are designed for the analysis of cells, many fail to perform adequately
on EVs due to their small size. There is one built for purpose NP-FC on the market. While it has excellent size
resolution, this comes at the expense of throughput (<200 events/sec), multiplexing capabilities (only two
channels), fluorescence sensitivity, and ease of use. All of this leaves EV researchers wanting for a more
comprehensive solution to better enable their critical studies correlating EV properties and reparative function.
Kinetic River has developed a built for purpose NP-FC. Preliminary data shows size sensitivity (via light
scattering) approaching that of the existing NP-FC. We propose to further develop this by improving three
aspects of performance: i) scattering and fluorescence sensitivity; ii) optomechanical design to enable five lasers
and up to six fluorescence detection channels; and iii) user experience, including throughput of up to 2,000
events/sec and a simple, automated size calibration method. In collaboration with EV researcher Dr. Fatah
Kashanchi, we will evaluate the performance of the resulting instrument by addressing a key question in his lab
regarding the reparative function of stem cell derived EVs. If successful, this Phase I will result in an EV analyzer
with an unprecedented ability to fully identify and characterize EVs, paving the way for a Phase II where sorting
capabilities can be incorporated, enabling isolation of EV subfractions for further downstream functional studies.

Public health relevance
PROJECT NARRATIVE The focus of this proposal is to develop a high sensitivity flow cytometry-based extracellular vesicle (EV) analyzer. The EV analyzer would provide significant advantages over current EV analyzers, including the high throughput of flow cytometry and the ability to simultaneously analyze, on a particle-by-particle basis, a proxy of size via light scattering and the presence of specific molecular markers via sensitive fluorescence analysis.